Defining the contributions of cerebello-spinal projection neurons to dexterous movement

PROJECT SUMMARY
The cerebellum is a brain structure long known to be essential for coordinating the contraction of muscle groups
across joints to enable smooth and precise limb movement. Output pathways in the cerebellar nuclei are thought
to continuously generate rapid corrective signals that ensure precision during skilled movements through a
process termed online correction. Up until now it has been difficult to identify and characterize the specific neural
circuits that could implement this rapid refinement due to the lack of selective access to cerebellar output
pathways. Recent work has shown that a subset of cerebellar output neurons project directly to the spinal cord
(cerebello-spinal), providing a possible pathway for rapid and direct adjustments of the limb. However, little is
known about the precise influence direct cerebello-spinal (CbSp) projections have on motor output and the
timescale on which activity in these circuits may act to ensure the accuracy of dexterous behaviors. No research
has explicitly investigated whether direct projections from the cerebellum to the spinal cord mediate rapid, online
corrections. The overarching goal of this proposal is to define how output from the cerebellum enables skilled
movements, focusing specifically on the functional role of CbSp projections and their influence on forelimb
movements. The central hypotheses are: 1) CbSp projection neurons convey online corrective commands that
refine forelimb movement; and 2) this refinement is achieved through activity patterns that encode predictions
about limb kinematics or muscle activity. Employing a skilled water reaching assay, CbSp projections will be
optogenetically silenced during performance of behavioral tasks designed to introduce sources of movement
error, such as changing reach target location. Kinematic and electromyography (EMG) analyses of performance
will uncover the precise corrective role of CbSp neurons in forelimb movements. Next, multielectrode silicon
probes will be used to record from CbSp neurons during performance of the same water reaching tasks. Single
unit activity analyses and generalized linear models trained on kinematic and neural activity data will reveal
whether CpSp activity predicts corrective movements and encodes specific features such as muscle recruitment,
limb velocity, acceleration, or trajectory. Moreover, analysis of data from both Aims will determine whether CbSp
neurons mediate corrective signals to the forelimb during dexterous movements. This work will provide valuable
insight into the neural basis of dexterous movement by expanding knowledge of how the cerebellum facilitates
the speed and precision of forelimb behaviors. This research will help lay the groundwork for improved diagnosis
and treatment of cerebellar pathologies.

Public health relevance
PROJECT NARRATIVE Dexterous movements require significant coordination of muscle groups across multiple joints, and the cerebellum is critical for ensuring that these behaviors are smooth and precise. This proposal seeks to define the contributions of an underexplored cerebellar output pathway to the spinal cord to the rapid refinement of skilled forelimb movements. By expanding our knowledge of how the cerebellum facilitates the speed and precision of forelimb behaviors, this work will provide valuable insight into the neural basis of dexterous movement, and lay the groundwork for improved diagnosis and treatment of cerebellar pathologies.